Role of environmental exposure and inflammation on hematopoietic stem cell disorders

PROJECT SUMMARY/ABSTRACT
Environmental exposures, including industrial pollution, automobile exhaust, military burn pits, forest fires, and
catastrophic events like the World Trade Center (WTC) collapse, release harmful pollutants such as polycyclic
aromatic hydrocarbons (PAHs). These exposures pose significant health risks, including chronic inflammation,
cardiovascular disease, lung disease, and an increased susceptibility to hematologic disorders. Our preliminary
findings indicate that such exposures increase the incidence of clonal hematopoiesis (CH) and associated
hematopoietic defects in exposed individuals, driving inflammation and impairing stem cell function. CH, marked
by the expansion of hematopoietic cells with somatic mutations (e.g., DNMT3A, TET2), is linked to cardiovascular
disease, bone marrow failure, and reduced survival.
This project aims to elucidate how environmental exposures lead to hematopoietic stem cell (HSC) dysfunction
and the progression of CH. We hypothesize that environmental pollutants trigger inflammation and DNA damage
in HSCs, leading to premature aging and the expansion of mutant clones. Specific Aim 1 will investigate whether
environmental exposures accelerate hematopoietic aging, particularly through the activation of inflammatory
pathways, by leveraging a unique, well-annotated cohort of human blood samples from individuals with
documented genotoxic WTC exposure, alongside genetically engineered murine models of environmental
exposure. Specific Aim 2 will assess whether exposure-induced genomic instability drives inflammation, explore
the underlying mechanisms, and determine if inhibiting inflammatory regulators can reduce mutation
accumulation and rescue HSC defects. This aim will also evaluate the therapeutic potential of targeting
inflammatory pathways, using murine models and a clinical-grade inflammasome inhibitor that has demonstrated
safety and efficacy in reducing inflammation in a pilot clinical trial with healthy individuals.
By integrating human samples and innovative in vivo models, this research will uncover critical insights into the
molecular mechanisms linking environmental pollution to hematopoietic aging and CH progression. These
findings could lead to novel therapeutic strategies to mitigate exposure-related hematopoietic dysfunction and
disease.

Public health relevance
PROJECT NARRATIVE This project will investigate how genotoxic environmental exposures, including pollutants from industrialization and events like the World Trade Center disaster, impair hematopoietic stem cell (HSC) function and accelerate hematopoietic aging. Leveraging a unique, well-annotated large cohort of human blood samples with a documented history of genotoxic environmental exposure and genetic in vivo models, we will examine the roles of inflammation and genetic instability in driving HSC dysfunction. Using a clinical-ready inflammasome inhibitor and innovative genetic in vivo models, we will explore potential therapeutic strategies to mitigate exposure-induced HSC defects, providing insights into preventing hematopoietic disorders.